Admin Core

PROJECT SUMMARY
The Administrative Core will provide essential support to the Coriell Institute for Medical Research (Coriell) and
Van Andel Institute (VAI) Epigenetic Therapy SPORE PIs and investigators to maximize success. It will be co-
directed by Drs. Jean-Pierre Issa, Stephen Baylin, and Peter Jones, who co-chair the Executive Committee and
provide overall supervision of three Projects, two additional Cores, Developmental Research (DRP) and Career
Enhancement (CEP) Programs, and scientific direction of the SPORE. The Core Co-Directors will rely on the
extensive broad-based scientific, research, and SPORE experience of the Internal and External Advisory Boards
in critical decision making. An oversight committee consisting of the SPORE PIs and three clinical experts from
the VAI-SU2C team (Drs. Rudin, El-Khoueiry and O’Connell) will ensure prioritization of SPORE trials within the
VAI-SU2C team and at clinical sites. Success of the complex interdisciplinary research in the SPORE depends
on integration of diverse epigenetic therapy research approaches. The Core will overcome barriers to
interdisciplinary collaboration and data sharing and will ensure a unified translational research effort. The SPORE
will be founded on planning, integration, and translational research efforts supported by this Core. Its leadership
and staff will be responsible for monitoring/planning scientific activities; providing scientific direction; ensuring
emphasis on translational research; ensuring interdisciplinary and inter-SPORE integration with major epigenetic
therapy programs within/outside Coriell and VAI and other broad translational research activities; and providing
optimal administrative and fiscal management. Specific responsibilities of the Core are: oversee and monitor all
SPORE activities; promote integration and communication among the SPORE-related clinical programs; monitor
the scientific integrity of all projects, and grant awards; assure compliance with institutional, governmental, and
National Cancer Institute regulations; oversee the fiscal and budgetary activities of the SPORE; coordinate data
control quality assurance issues; coordinate activities associated with clinical trials, including design of protocols,
approval by regulatory bodies, implementation, and eligibility screening and assignment of patients to different
studies; provide oversight and support for the shared Resources Cores; coordinate and manage meetings of the
SPORE Oversight Committee, Executive Committee, Internal and External Advisory Boards, investigator
meetings, research meetings, lectures, and symposia; administer the DRP and the CEP; coordinate
interdisciplinary and inter-SPORE interactions and exchanges/meetings with other Epigenetic Therapy SPORE
programs and investigators, and other SPORE programs; administer the activities of the Patient Advocates;
comply with, and improve policies addressing recruitment and retention of women and minorities; and maintain
a Epigenetic Therapy SPORE website focused on issues in epigenetic therapy translational research in cancers.

Public health relevance
PROJECT NARRATIVE The Administrative Core will provide the support and infrastructure for research and financial oversight; clear and open communications among all SPORE investigators, patient advocates, and developmental awardees; and regulatory monitoring to optimize the successful outcome of the translational research in epigenetic therapy for cancer.